HORMONE-DEPENDENT GROWTH AND DIFFERENTIATION OF THE MAMMARY GLAND

In order to obtain further evidence for our hypothesis that epidermal growth factor (EGF), a polypeptide hormone produced by submandibular glands, plays a role in the development of murine mammary gland, we performed sialoadenectomy (removal of the submandibular gland) of virgin mice to examine its subsequent effect on mammary tissue development during pregnancy and lactation. These studies showed that pregestational sialoadenectomy decreases the growth of the mammary gland and its capacity to synthesize milk, resulting in an increase in offspring mortality and delayed eyelid opening of pups. EGF administration to sialoadenectomized pregnant mice, however, increases survival rate of offspring and enhances eyelid opening to a normal level. The concentration of EGF in the submandibular gland and plasma of adult female mice was found to increase significantly during gestation. Similar studies using sialoadenectomized mice indicated that the plasma concentration of EGF decreases to an undetectable level, suggesting that submandibular EGF is largely responsible for the increase in plasma EGF which occurs during gestation. Additional studies showed that the concentration of EGF in the submandibular gland of virgin female mice increases as much as 9-fold during post-reproductive stage. During this period the incidence of mammary tumor in virgin females increased markedly to a maximal level of 62.5% at 52 weeks of age. Removal of the submandibular gland of virgin mice at 14-22 weeks of age reduced the tumor incidence to 12.8% and also increased the latency period of mammary tumor development as much as 14 weeks when compared to that of normal mice. Long term treatment of sialoadenectomized virgin mice with EGF increased the tumor incidence to 33.3%. Moreover, sialoadenectomy of mammary tumor-bearing animals caused a rapid and sustained cessation of tumor growth, but EGF administration quickly restored the rate of tumor growth to a normal level. These results indicate that submandibular gland EGF plays a crucial role in the development of mouse mammary gland during pregnancy as well as in mammary tumorigenesis.